Mechanical programming to enhance the immunosuppressive function of mesenchymal stem cells for the treatment of graft-versus-host disease.

SPECIFIC AIMS
Mesenchymal stem/stromal cells (MSCs) are potent regulators of immune cells, and their immunosuppressive
function is being actively investigated for a number of therapeutic applications. In particular, it has been
demonstrated that MSCs can inhibit the proliferation of effector T cells and induce regulatory T-cell
differentiation for treating graft versus host disease (GvHD). A few MSC products have been approved by
regulatory agencies in countries outside of the U.S. However, MSCs have not always shown consistent
efficacy in GvHD clinical trials. This is in part due to the challenges of generating MSCs with consistent, high
therapeutic potency. The overarching goal of this project is to develop MSC therapies with enhanced
immunosuppressive efficacy for GvHD treatment by identifying and providing optimal microenvironment
mechanical cues in MSC production. Mechanical cues from cell microenvironment play important roles in
regulating cell behavior. For example, studies have shown that matrix stiffness directs cell activity and fate
such as migration, proliferation, and differentiation. However, matrix or material stiffness only describes their
static, elastic mechanical property. Instead of being simply elastic, natural extracellular matrix (ECM) and living
tissues are viscoelastic, exhibiting stress relaxation over different characteristic time scales (stress relaxes at
different rates). We have developed a hydrogel system that can recapitulate the stiffness and viscoelastic
behavior of different types of tissues. Using the hydrogels as culture substrates, we discovered that matrix
stress relaxation, in addition to stiffness, is an important mechanical factor regulating cell–ECM interactions
and directing MSC activities including spreading, proliferation, differentiation, and in vivo bone regeneration. In
collaboration with Dr. Kyung Sung at FDA, we recently found that substrate stress relaxation also regulates
MSC's immunosuppressive capacity and their ability to inhibit T cell proliferation; Interestingly, MSCs retained
their mechanical “memory” even after being extracted from the hydrogels (see preliminary data section). In
light of these new findings, we hypothesize that biomaterials with tailored stress relaxation properties can
provide inducing mechanical cues in MSC production to enhance MSC's immunosuppressive efficacy for
GvHD treatment. We will test this hypothesis in the following specific aims: Aim 1: Elucidate the molecular
mechanisms by which matrix stress relaxation regulates the immunosuppressive capacity of human MSCs
(hMSC) derived from bone marrow. Aim 2: Compare the effect of matrix stress relaxation on hMSCs derived
from different tissues or hMSC subpopulations sorted by integrin expression. Aim 3: Evaluate the efficacy of
hMSCs primed by viscoelastic hydrogels with different stress relaxation properties for GvHD treatment in an
animal model. This project uses multidisciplinary approaches to study hMSC mechanobiology. Successful
completion of these aims will have significant impact in understanding how matrix mechanical cues regulates
the immunosuppressive capacity of hMSCs, with the findings potentially leading to better treatment for GvHD.

Public health relevance
Project Narrative Mesenchymal stem/stromal cells (MSCs) are potent regulators of immune cells, and they have demonstrated immunosuppressive function for treating graft versus host disease (GvHD) in animal models and clinical trials. While current research on optimizing MSCs for GvHD treatment has primarily focused on using biochemical factors to enhance their immunosuppressive capacity, how mechanical cues affect MSC's immunosuppressive function is poorly understood. In this project, we will utilize tailored biomaterials to study how matrix mechanical factors regulate the immunosuppressive capacity of MSCs and explore how mechanical cues can be exploited to enhance MSC's efficacy for GvHD treatment.